Chromatin Architecture Regulatory Mechanisms in Pathogenesis of B-Cell Lymphomas

PROJECT 2: PROJECT SUMMARY
Cell fate transitions and cancer phenotypes depend upon the establishment of specific transcriptional programs.
The dynamic folding of chromatin acts as a key regulatory layer of gene expression and cell identity by allowing
select chromatin regions to facilitate transcription factor (TF) action, spatiotemporal rewiring of enhancers with
their target promoters, and transcription. We found that cell fate determining genes tend to reside within
architectural topographies that we call CRE hubs, which consist of networks of interacting enhancers and
promoters anchored by highly connected architectural hotspots. Thanks to the development of the Pore-C
method, with our collaborators we have now discovered that CRE hubs can form larger assemblies called
chromunities, through bridging elements that connect CRE hubs. However, the underlying mechanisms of
formation and regulatory potential of CRE hubs and chromunities are not well understood. Based on our
preliminary data generated through this P01 grant, we found that cohesin and CTCF play a critical role in
assembling enhancer loops within hubs in germinal center B-cells, from which most B-cell lymphomas arise. We
performed the first CRISPR screen of a CRE hub enhancer and identified the biochemical mechanisms that
explain its ability to form in a cell context specific manner. We also discovered that loss of chromatin folding due
to histone 1 (H1) mutations in lymphoma can release stem cell enhancers from silenced chromatin
compartments, endowing B-cells with stem-like properties. Therefore we hypothesize that (i) physiological
reprogramming of CRE hub and chromunity regulatory elements creates de novo coordination between sets of
genes required to establish specific cell states and phenotypes during the humoral immune response, (ii) SVs
occurring in DLBCL alter these CRE hub and chromunity structures or create new ones giving a selective
advantage to malignant clones, and (iii) rewiring of epigenetic compartments induced by H1 mutations results in
architectural and plasticity permitting formation of aberrant oncogenic CRE hubs. Finally, we predict that analysis
of mechanisms supporting this process represents a therapeutic vulnerability in B cell lymphomas. Therefore,
we will (i) identify CRE hubs and chromunities driving phenotypic transitions and cell fate decisions during the
humoral immune response, (ii) explore how these structures mediate cell lineage identity, (iii) determine how
aberrant genomic structures in lymphoma patients create oncogenic driver chromunities, and (iv) establish
whether and how mutations in epigenetic modifiers drive lymphoma phenotype by forming malignant aberrant
chromunities. This work will provide fundamentally novel insight into the role, mechanism of action and biological
relevance of 3D CRE hubs, chromunities and their regulatory hotspot elements in controlling cell identity and
driving malignant transformation, as well as explain how they evolve from oncogenic genetic or epigenetic
lesions.

Public health relevance
PROJECT 2: NARRATIVE Based on preliminary data arising from the first five years of work, we hypothesize that architectural CRE hubs and chromunities play a central driving role in cancer with a focus on B-cell lymphoma. We will establish the baseline for dynamic hub and chromunity assembly in B cells during the humoral response, determine whether aberrant cancer driving CRE hubs arise from genetic and or epigenetic determinants, and identify transcriptional mechanisms involved in deregulating the gene networks involved.